Statistical Methods for Network-based Integrative Analysis of Microbiome Data

Project Summary
The past decade has seen substantial progress in the discovery of microbiome biomarkers associated with hu-
man health and diseases. However, despite the exciting prior work, we currently still lack an understanding of the
mechanism by which the gut microbiome impacts human health. An outstanding challenge is how to integrate
microbiome and other -omics data types generated in microbiome multi-omics proﬁling studies to elucidate mi-
crobial functional pathways. Unfortunately, available statistical methods for integrative analysis do not adequately
address the analytical challenges speciﬁc to microbiome data. Microbiome data are compositional, zero-inﬂated,
high-dimensional, and highly structured where samples are related by ecologically deﬁned distances and taxa are
related by their phylogeny. We propose to use our expertise in network analysis and high-dimensional statistical
inference to tackle these challenges unique to microbiome data analysis. Our overall objective is to develop rigor-
ous statistical methods that yield reliable and powerful inferences relating microbial functional pathways with host
health conditions. The proposed methodologies are motivated by our collaboration with the Study of Latinos and
the Dog Aging Project, and include a novel inference procedure for joint analysis of microbial and metabolomic
networks (Aim 1), a novel method for joint dimensionality reduction which incorporates prior biological knowledge
about the relationships between samples and between variables (Aim 2), and a powerful framework for jointly
associating microbiome and other -omics data types with health outcomes (Aim 3). We will develop efﬁcient and
easy-to-use software tools for the proposed methods (Aim 4). This work is innovative and signiﬁcant, because it
will provide systems biology insights into the role of the microbiome and has the potential to make a major impact
on the identiﬁcation of novel microbiome biomarkers. Successful completion of this proposal will generate impor-
tant community resources, including new methodologies for integrative analysis and their user-friendly software
tools. With these analytical tools, the longer-term goal of this project is to hasten the discovery of microbiome-
based therapeutic targets and contribute to the development of microbiome-based precision therapies.

Public health relevance
Project Narrative Microbiome studies routinely collect multiple -omics data types in order to understand the mechanism by which the microbiome impacts human health and diseases. This project develops novel statistical methods for analysis of microbiome and other -omics data types. The proposed methods will provide systems biology insights into the role of the microbiome in human health and pave the way for intervening the microbiome to address various public health problems.